SCH: Machine LEarning & MicrofluiDics for Multimodal Sensing of TiCk-bOrne Diseases(MEDICO)

PROJECT SUMMARY (See instructions):
The incidence of tick-borne diseases (TbD) is increasing, with ~500k reported cases during 2004-2016
from the National Notifiable Diseases Surveillance System of the Centers for Disease Control (CDC), and
is expected to increase due to global climate change. Some of the most common TbD in the U.S. include
anaplasmosis, babesiosis, and Lyme disease transmitted by the same tick vector, I. scapularis. Lyme
disease is especially pernicious because it is difficult to diagnose early, often misdiagnosed, and is difficult
to treat. Because current diagnostic methods are insufficiently sensitive or non-existent, we propose a
novel approach for diagnosis via a microfluidic platform with an integrated multimodal sensing system and
machine learning (ML) algorithm. Based on our preliminary and published data, we hypothesize that we
can detect TbD and their coinfections from whole blood. Central to our vision is a system designed for
minimal user intervention to detect and measure complex cell data using ML. The diagnosis of TbD will be
achieved through three objectives: 1) design a dielectrophoresis (DEP) based platform for detecting TbDs
from whole blood; 2) design 3D sensors and a readout integrated circuit (ROIG) for sensitive in-vitro
detection of cells; and 3) develop an ML algorithm to diagnose early-stage Lyme disease, babesiosis, and
anaplasmosis. An extremely sensitive (<0.1aF), low-voltage (1.8V for core & 3.3V for 10), low-power
(<10mW), multi-channel (~16-ch), high-speed (~5MSample/sec per channel) readout integrated circuit
(ROIG) will be integrated to detect single-cell behavior at high resolution (~10-bit resolution). The novel ML
algorithm(s) will use cell data to determine the type of infection intelligently, reducing >96Gbit data during
each diagnostic cycle (~2min) into as simple as 1-byte diagnostic information (i.e., 1: positive, 0: negative)
per tested population of the cells or disease. Further, an open-source program to diagnose TbD will be
created and made available freely from a public software repository. This developed diagnostic technology
will simultaneously meet high-sensitivity, low-power/voltage, high-purity, and high-viability performance
metrics by cutting the diagnosis time from 4-6 weeks (late stages) to <30 min (early stages). The proposed
research will lead to faster diagnosis, reducing the hospitalization, morbidity, and mortality associated with
TbD and their coinfections.

Public health relevance
RELEVANCE (See instructions): Tick-borne Disease (TbD) in the US has tripled due to both vector range expansions and emergence of novel tick-transmitted pathogens, leading to increased morbidity and mortality. A major limitation of the current detection techniques is the extreme bias towards detecting single pathogens and lack of consideration of coinfections. Our MEDICO platform will diagnose babesiosis, anaplasmosis, and acute, early-stage Lyme disease that share the same tick vector, I. scapularis, and often coexist.